Role of the N-terminal Region in Abeta Oligomer and Fibril Formation

? DESCRIPTION (provided by applicant): Oligomeric intermediates of amyloid-β (Aβ) peptide formed on the pathway of Aβ aggregation have been suggested to have potent neurotoxic activities in Alzheimer's disease (AD). The hydrophilic and charge-rich N-terminal region of Aβ, which is highly disordered in amyloid fibrillar structure, has been recently suggested to play an important role along the aggregation pathway. However, the mechanistic details and dynamic regulating function of the N-terminal region in Aβ aggregation still remain unclear. We hypothesize that the amphiphilic property of the N-terminal sequence is crucial for its regulating function in Aβ aggregation. Particularly, electrostatic interactions that the N-terminal charged residues are involved in, play a critical role in directing Aβ early assembly and determining the morphology and metastability of oligomeric intermediates. The objective of this proposal is to clarify the mechanistic details of the N-terminus in Aβ aggregation including the local aggregation dynamics and conformational transition by using sensitive optical probes, and identify the driving forces that direct Aβ self-association by employing systematic site-directed mutagenesis in conjunction with biophysical and biochemical approaches. An unnatural amino acid p-cyanophenyl-alanine will be used to elucidate the local environmental changes and conformational dynamics along the aggregation at a residue-specific level. The Specific Aims are: (1) Determine local dynamics and conformational transition of the N-terminal region in Aβ aggregation; (2) Identify crucial interactions at the N-terminal region in Aβ oligomerization and fibrillization; and (3) Determine the effect of interplay between Aβ and charged macromolecules on Aβ aggregation. The outcome of the proposed research will complement and expand the current efforts toward a comprehensive understanding of the mechanism(s) of Aβ aggregation and the structure-toxicity relationship for the oligomeric intermediates. In addition, we expect that the knowledge from this research will facilitate the identification of novel targets, such as the key residues and crucial interactions at the N-terminal region, for rational design of strategies to modulate Aβ aggregation, which may ultimately lead to the development of new therapeutic treatment for AD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alzheimer's disease is a progressive neurodegenerative disorder, which is responsible for 50-80% of all cases of dementia. Emerging evidence suggests that the oligomeric, diffusible assemblies of amyloid -peptide (A) appear to the primary toxi species in Alzheimer's disease, while the mechanistic details of A oligomerization remain largely elusive. The proposed project is relevant to public health because we aim to elucidate the underlying mechanism(s) of Aß oligomerization, which will enable the identification of novel therapeutic targets and facilitate the development of new strategies for therapeutic treatment to Alzheimer's disease.